Brain basis and neural circuitry of habit-like attention in infants and adults

Project Summary/ Abstract
The brain has the ability to filter and prioritize a cacophony of often extraneous visual stimuli via a mechanism
called attention. Attentional control is present even at birth and is tuned throughout development. Traditionally,
attention is thought to be guided by either a goal-driven mechanism (top-down, supported by fronto-parietal
brain networks) or a stimulus-driven mechanism (bottom-up, supported by visual networks). These
mechanisms also follow distinct developmental trajectories where top-down attention reaches maturity slower
than bottom-up attention due to the delay of frontal cortex development. However, recent work has highlighted
a type of attention that does not fit within this dichotomy: one driven by prior experience (i.e., selection history)
that can be characterized as a habit. This habit-like attention demonstrates behavioral inflexibility, deficits in
attentional and basal ganglia disorders, and is present throughout the lifespan from infancy to old age. Despite
extensive behavioral research, the underlying neural circuitry is debated in adults, and unknown in infants and
children. Here, we aim to characterize the neural underpinnings of habit-like attention to elucidate how prior
experience can bias attention as early as infancy. We hypothesize that this newly identified mechanism of
attention is driven by subcortical structures. We will utilize neuroimaging—task-based (using a contextual
cueing paradigm), structural (diffusion-weighted imaging), and functional (resting state) connectivity—in both
healthy adults (18+) and infants (6—10 months). We will utilize state-of-the-art neuroimaging techniques with
specialized protocols for infants and for adults and hierarchical Bayesian modeling to ensure robust individual
estimation of neural activity to Aim 1: Identify the neural structures that support habitual attention.
Further, we will relate predict individual neural organization from structural and functional connectivity to
individual behavior using machine learning to Aim 2: Characterize the prototypical infant and adult
dynamics between cortico-striatal circuitry and relate each individual’s connectivity fingerprints to the
strength of their attentional habits a) within their age group b) between their age groups. Elucidating
the neural underpinnings of habit-like attention may allow us to better understand, identify, and treat cognitive
deficits in attention related-disorders in children, and Huntington’s and Parkinson’s diseases later in life.
Moreover, this work will characterize individual differences in attentional habits from early in development and
may reveal ways to improve attentional habits in both children and adults. This proposal has the necessary
resources and well-matched team to uncover the neural basis of habit-like attention, which has exciting
implications for early prediction and potential interventions for future attentional deficits.

Public health relevance
Project Narrative We explore the existence of a new attentional mechanism, one that is habit-based and that does not fit into the traditional dichotomous model of attention, and importantly, develops early and is present in infancy. Deficits in habit-like attention are observed throughout the lifespan in children with attentional disorders (e.g., ADHD) and in older adults with basal ganglia degeneration (e.g., Huntington’s and Parkinson’s diseases). This proposal will reveal the neural basis of habit-like attention and its individual variation in infants and adults, which has large implications for public health by predicting future risk factors, potential screening tools, early interventions, and offering a deeper understanding of attentional deficits throughout the lifespan.